Aerosolized Chemically Modified Tetracycline Nanoformulation for the Treatment of Acute Respiratory Distress Syndrome

PROJECT SUMMARY/ABSTRACT
CMTx Biotech is a drug development company working to rescue, develop and commercialize a proprietary
clinical-stage drug candidate, incyclinide (CMT-3 / COL-3), for the treatment of sepsis patients at risk of acute
respiratory distress syndrome (ARDS). According to the U.S. Centers for Disease Control (CDC), at least 1.7
million American adults develop sepsis annually, resulting in nearly 270,000 deaths. Sepsis accounts for more
than 50% of hospital deaths, and mortality increases dramatically with greater disease severity: 10–20% for
sepsis, 20–40% for severe sepsis, and 40–80% for septic shock. Sepsis is a medical emergency characterized
by severe immune dysregulation with a very complex immunopathogenesis. ARDS is a devastating complication
of severe sepsis, both with similar underlying mechanisms characterized by inflammation and endothelial
dysfunction. Sepsis is the leading cause of ARDS and accounts for 32% of the etiology of the condition.
Approximately 6-7% of sepsis patients rapidly progress to ARDS, which is associated with a significantly
increased risk of in-hospital mortality. There is currently no specific treatment for sepsis-induced ARDS.
Moreover, researchers have not yet elucidated the multifactorial mechanisms by which sepsis induces ARDS,
or why the inflammatory cytokine storm eventually induces diffuse alveolar damage and severe hypoxia. Though
advances in treatment modalities have improved the outcome over recent decades, including lung protective
ventilation, prone positioning, use of neuromuscular blockade, and extracorporeal membrane oxygenation, the
mortality rate still remains high. There remains a critical unmet need for the development of safe and efficacious
therapeutics to prevent the onset of sepsis-induced ARDS, protect against lung injury and improve survival.
CMTx Biotech is working to develop and commercialize a novel and proprietary nanoformulation of incyclinide
(nCMT-3) that can be aerosolized, and which can be delivered to specifically target the lung and treat sepsis-
induced ARDS while limiting systemic toxicity. Incyclinide is a clinical-stage, non-antibiotic, chemically-modified
tetracycline that belongs to a class of pleiotropic matrix metalloproteinase (MMP) modulators which inhibit
pathologically-excessive collagenolysis and resolve systemic inflammation. Importantly, the safety of incyclinide
has already been demonstrated in Investigational New Drug (IND)-enabling studies, and incyclinide has been
evaluated in a number of human clinical trials for the treatment of diseases as disparate as AIDS-related Kaposi’s
sarcoma, recurrent high-grade gliomas, refractory metastatic cancer, acne, rosacea and periodontitis. Published
pre-clinical efficacy studies have shown that systemic administration of incyclinide prevents the development of
ARDS and septic shock, and improves survival in several chronic insidious onset animal models of ARDS across
several species, including mice, rats, pigs, and sheep. Our long-term goal is to obtain regulatory approval from
the FDA and comparable international regulatory authorities to market aerosolized nCMT-3 for the treatment and
prevention of sepsis-induced ARDS. We strongly anticipate that nCMT-3 will inhibit disease progression, mitigate
acute lung injury and respiratory distress, reduce the need for intensive care and intubation, and improve clinical
outcomes for sepsis patients, including overall survival. Our specific aims are (a) to determine the
pharmacokinetics, biodistribution, and safety of aerosolized nCMT-3 in mechanically ventilated pigs with healthy
lungs, (b) to demonstrate the efficacy of aerosolized nCMT-3 in reducing the incidence and mortality of sepsis-
mediated ARDS in a high-fidelity, clinically applicable porcine sepsis-induced ARDS model, and (c) to
demonstrate the efficacy of aerosolized nCMT-3 at reducing local and systemic inflammation. Successful
completion of these studies will allow CMTx Biotech to advance nCMT-3 towards human clinical trials for the
treatment of ARDS patients.

Public health relevance
PUBLIC HEALTH STATEMENT / PROJECT NARRATIVE According to the U.S. Centers for Disease Control (CDC), at least 1.7 million American adults develop sepsis annually, resulting in nearly 270,000 deaths. Sepsis accounts for more than 50% of hospital deaths, and mortality increases dramatically with greater disease severity: 10–20% for sepsis, 20–40% for severe sepsis, and 40–80% for septic shock. Sepsis is a medical emergency characterized by severe immune dysregulation with a very complex immunopathogenesis. ARDS is a devastating complication of severe sepsis, both with similar underlying mechanisms characterized by inflammation and endothelial dysfunction. Sepsis is the leading cause of ARDS and accounts for 32% of the etiology of the condition. Approximately 6-7% of sepsis patients rapidly progress to ARDS, which is associated with a significantly increased risk of in-hospital mortality. This proposed project is directly relevant to the public health, since it is to repurpose and develop a promising, clinical-stage drug candidate for the treatment of this critical unmet medical need. Moreover, the drug candidate has also shown promise in a variety of other disease areas related to systemic inflammation, demonstrating the potential for broad application and societal benefit if proven to be both safe and effective.